Interacting Partners of Bestrophin Channels

Project Summary/Abstract
The bestrophin proteins are a family of Ca2+-activated anion channels widely distributed from bacteria to
mammals, with representatives in most metazoans including four in humans (Best1-4). They open in response
to increases of intracellular Ca2+ to mediate the passive flow of Cl− and other anions. Best1 and Best2 both have
critical roles in the eye. Best1 is predominantly expressed in retinal pigment epithelium (RPE) of the retina playing
an essential role in generating a vision-related electrical signal named “light peak”, while mutations in the human
BEST1 gene have been genetically linked to at least five retinal degenerative disorders collectively known as
bestrophinopathies. Best2 is highly expressed in non-pigmented epithelium (NPE) of the ciliary body, and is
involved in aqueous humor formation and drainage, which ultimately determine intra-ocular pressure (IOP).
Knockout of Best2 in mice leads to a reduction of IOP, suggesting the pharmaceutical potential of targeting Best2
and its regulators for relieving ocular hypertension, which is a common risk factor for numerous eye diseases
including open-angle glaucoma. However, despite bestrophins’ biological and pharmaceutical significance, little
is known about their cellular regulation in a physiological context. More specifically, in a given cell/tissue, how is
the bestrophin channel modulated to conduct which anion(s) for what downstream purpose(s)? The answer to
this question lies within the protein network that interacts with bestrophins in different tissues/cells. Although
ample evidence suggest the existence of tissue-specific interacting regulators of bestrophins, no protein is known
to interact with Best2, while only a few have been reported to interact with Best1. Our lab studies the biophysics
and regulation of bestrophin channels using a multidisciplinary platform consisting of cryogenic electron
microscopy (cryo-EM), mass spectrometry, electrophysiological recording, CRISPR/Cas9-mediated genome
editing, and stem cell reprogramming/differentiation. The goal of the next five years is to identify Best1 and Best2
interacting protein complexes in RPE and NPE, respectively, and to understand the functional consequences of
these interactions. Overall, the proposed work will make contributions to multiple fields of research including
calcium signaling, ion transport, membrane protein structure and ocular physiology, and the pipelines established
in this work can be generally applied to study different ion channels and other membrane proteins of interest.

Public health relevance
Project Narrative Bestrophins are a family of ion channels with critical (patho)physiological roles in the eye, as mutations of bestrophin-1 (Best1) cause retinal degenerative disorders, while bestrophin-2 (Best2) regulates intra-ocular pressure. This project is aimed to identify interacting protein partners of bestrophins and elucidate the structural and functional consequences of these interactions. The findings from this work will provide important knowledge on ocular physiology, and establish a versatile platform for investigating other ion channels of interest and their interacting partners.